ANALYSIS OF HIV INFECTION OF THE PEDIATRIC THYMUS

Since loss of CD4 positive cells is the hallmark of disease progression in HIV infection, understanding the interaction between HIV and the developing T cells in the thymus is crucial for gaining better insight into disease progression. The thymus is essential for normal T cell development and consists of predominantly CD4 positive immature T cell which as we and others have shown can be readily infected with HIV in vitro and in vivo. A productive HIV infection depends on virus strain and on the activation state of the target cell. Our hypotheses are; 1) that thymocyte subsets which are activated and/or proliferating are principle targets for HIV infection; 2) that cytopathic viral strains affect thymocytes at an earlier stage of maturation than non-cytopathic strains and 3) that depletion of thymocytes which produce IFN-gamma results in increased HIV expression by thymocytes and contributes to immunodeficiency. We have an unique opportunity to test these hypotheses using clinical viral isolates in a three-dimensional model comprised of in vitro thymocyte suspension culture, thymus organ culture and thymus grafts in the SCID/hu mouse. The following is an outline of our experimental strategy. We will test which thymocyte subsets are infected and expressing virus y sorting of immature and mature thymocytes subsets after in vitro and in vivo (SCID/hu mouse) infection of thymocytes with isolates of different pathogenicity. In addition, we will compare the functions of HIV-infected with sham-infected thymocyte subsets. We will investigate the regulation of HIV infection in the thymus by IFN-gamma, since we have found that IFN-gamma inhibits HIV production by thymocytes in vitro. Low iFN-gamma levels at birth could be one factor in perinatal HIV transmission. The study of the effects of viral isolates with different cytopathogenicity on the maturation and function of immature T lymphocytes in the thymus provides an opportunity to define indicators of disease aggressiveness in pediatric patients and specific targets for medical intervention.